Endothelial Sphingolipid Signaling in Post-Sepsis Cognitive Impairment.

PROJECT SUMMARY
Post-sepsis neurocognitive impairment is a devastating sequela of severe sepsis causing long-term disability in
up to ~50% of sepsis survivors and accelerating the onset of dementia and the need for institutionalization in
the elderly. The cellular and molecular mechanisms leading to neurocognitive dysfunction in sepsis survivors
are not well understood making the cause of this devastating complication difficult to predict, prevent, or treat.
While there is evidence that blood brain barrier (BBB) dysfunction during sepsis associates with neurocognitive
impairment, the endothelial signaling pathways governing BBB permeability and their impact on cognitive
dysfunction are not well understood. The sphingosine-1-phosphate (S1P) pathway regulates endothelial
function via G-protein coupled receptors (S1PR). Under the parent R01, we have found that S1PR2 is potently
induced in cerebral microvessels during stroke leading to BBB leakage and brain injury. However, we do not
know how endothelial S1PR2 affects the BBB and cognitive dysfunction during sepsis, which is restricting the
investigation of its potential value as a therapeutic target to prevent this devastating complication. The
objective of this administrative supplement is to determine the role of endothelial-specific S1PR2 signaling in
sepsis-induced BBB permeability and cognitive dysfunction. Our central hypothesis is that during sepsis,
upregulation of S1PR2 in cerebral microvessels induces BBB dysfunction and it can be targeted as novel
vasoprotective therapy to ameliorate cognitive impairment. This hypothesis is supported by our data using
mouse models of sepsis and unique reagents and resources validated in our investigative team under the
parent R01, such as tissue specific genetically engineered mice, novel methods to conduct molecular assays
in cerebral microvessels, first-in-class S1PR2 antagonists and behavior tests to assess cognitive function in
mice. In this request for supplemental funding, we aim to pursue two important extensions of the existing grant.
The first goal is to determine the role of endothelial S1PR2 in cerebral microvascular (BBB) dysfunction and
post-sepsis cognitive impairment. This work extends aim 1 of the original R01 in which we have found that lack
of S1PR2 specifically in the endothelium mitigates brain injury in stroke. The second goal is to determine the
efficacy of a novel S1PR2 antagonist to mitigate sepsis-induced BBB and cognitive dysfunction. This work
extends aim 3 of the parent R01, in which, we have validated the efficacy of a novel S1PR2 antagonist in
stroke. The proposed pilot studies are highly relevant to the understanding of the vascular contributions to
dementia because they are expected to provide initial proof of the role of endothelial S1PR2 in BBB leakage
and post-sepsis cognitive dysfunction and the therapeutic potential of this pathway. This initial evidence will be
critical for a future R01 submission aiming at investigating the cellular and molecular mechanisms governing
sepsis-induced BBB and neurocognitive dysfunction. Understanding the role of the cerebral microvasculature
in dementia will help the development of novel therapies for this devastating condition.

Public health relevance
PROJECT NARRATIVE Neurocognitive dysfunction is a devastating sequela of severe sepsis causing long-term disability in up to 50% of sepsis survivors, accelerating the onset of dementia and the need for institutionalization in the elderly. Cognitive dysfunction is major driver of post-sepsis health care costs and is expected to disproportionately increase US medical expenditures going towards the care of COVID-19 survivors. The proposed research will help understand the role of the vascular system in sepsis associated-cognitive dysfunction and dementia so that novel therapies can be developed to improve the quality of life of elderly patients.